Disentangling the Consequences of Trauma

PROJECT SUMMARY/ABSTRACT
Trauma impacts the life of nearly every individual and plays a pivotal role in shaping our mental health, leaving
individuals vulnerable to an array of debilitating psychological conditions, including post-traumatic stress
disorder, substance use disorders, anxiety, and depression. Much trauma research has focused on how
memories for traumatic events are formed, with considerably less emphasis on the multifaceted processes
contributing to these conditions. Further highlighting the importance of examining multiple trauma endpoints,
growing evidence indicates that the consequences of trauma are behaviorally and biologically dissociable.
Thus, the diverse pathological consequences of trauma may require individualized treatment targets. The
experiments in this proposal will utilize a behavioral procedure that will allow the diverse consequences of
trauma to be simultaneously studied in mice, combined with a sophisticated set of techniques for isolating
biological variance, allowing for the disentanglement of their biological origins. Under the K99 portion of this
proposal – to be completed at the Icahn School of Medicine at Mount Sinai under the mentorship of Drs.
Denise Cai (primary mentor), Ian Maze (co-mentor), and Scott Russo (co-mentor) – I will first test the
hypothesis that trauma induces lasting changes in amygdala trauma ensembles (i.e., neurons active in
response to trauma) that results in enhanced responses to subsequent stressors, but not other anxiety-like
phenotypes. This will be achieved using a combination of in vivo calcium imaging and selective optogenetic
inhibition of trauma ensembles during subsequent behavioral tests. Further, I will use RNA sequencing of
trauma ensembles to determine the transcriptional changes specific to these cells, in hopes of discovering
novel targets for intervention. Technical training under the K99 portion will include optogenetics, fluorescence
activated nuclear sorting, and transcriptomic analyses. Additionally, I will receive vital career development
training on topics related to laboratory and personnel management, grant writing, communication/networking,
and entering a tenure track position at a top-tier academic research institution. Under the R00 portion of this
proposal, I will utilize a similar set of techniques to test the hypothesis that ventral hippocampal trauma
ensembles support persistent anxiety-like behaviors after trauma. This work will provide both key insights into
how trauma persistently influences anxiety-like behavior and robust preliminary data for my lab’s first grant
applications. The training and support provided by this award will be instrumental as I establish a successful
career focused on how trauma predisposes individuals to neuropsychiatric illness.

Public health relevance
Project Narrative Traumatic experiences shape us in profound and lasting ways, often producing serious mental health complications. The experiments in this proposal seek to uncover how trauma produces alterations in the brain that lead to distinct fear and anxiety responses. By combining a set of state-of-the-art tools that allow for the precise cells likely to support these responses to be persistently monitored, manipulated, and molecularly profiled, this proposal offers an unprecedented opportunity to advance new biological targets for disease intervention.